Mechanisms underlying caloric restriction-mediated resolution of atherosclerosis

PROJECT SUMMARY
Obesity and atherosclerosis are frequently comorbid conditions contributing to substantial morbidity and mortality
worldwide. The processes are characterized by inflammation in the adipose tissue and vasculature, respectively,
that share many pathophysiologic pathways. Although processes underlying obesity and atherosclerosis-related
inflammation are well studied, the signals that promote disease resolution and remission are largely unknown,
especially in the context of concomitant inflammation resolution. As a postdoctoral fellow, I investigated how
resolution of obesity-related inflammation influences cardiovascular disease and found that caloric-restriction-
induced weight loss in obese mice promotes resolution of atherosclerosis. Building upon these exciting findings,
I propose in Aim 1 to evaluate the impact of caloric-restriction on obese adipose tissue and hematopoietic
progenitors and whether the pro-resolving phenotype produced by to caloric-restriction can be transferred
through adipose or hematopoietic cell transplantation. In Aim 2, I propose to investigate the mechanisms by
which caloric-restriction influences the content and composition of atherosclerotic lesions and promotes
atherosclerosis resolution. This work will reveal novel functions of cells and tissues that influence the
atherosclerotic process in weight loss. Additionally, these studies will identify novel molecular pathways that may
be targeted for the concomitant treatment of adipose tissue and atherosclerosis-related inflammation.

Public health relevance
PROJECT NARRATIVE Atherosclerosis is the leading cause of death worldwide and obesity is a major risk factor for the development of atherosclerosis and other metabolic diseases. My exciting data show that weight loss induced by caloric- restriction promotes resolution and remission of atherosclerosis and I propose to study the underlying mechanisms. My studies will uncover novel pathways responsible for the concomitant resolution of obesity and atherosclerosis.